Emulated Target Trials and Phenotyping in Patients with Acute Respiratory Distress Syndrome

PROJECT SUMMARY/ABSTRACT
Acute respiratory distress syndrome (ARDS) is a severe form of lung injury with significant public health
implications due to severe morbidity and mortality. The need to utilize existing data to inform prospective
research and clinical decision making was emphasized during the COVID pandemic, when ARDS became a
leading cause of death, and clinicians were forced to operate outside of existing evidence. Many commonly
applied interventions including use of neuromuscular blockade (NMB), steroids, driving pressure and mechanical
power are used despite negative data, without high quality prospective studies or with equivocal evidence and
with the potential for both benefit or harm. Additionally, phenotypes of ARDS may have different prognosis and
response to treatment, but thus far have not been well differentiated using routinely available dynamic clinical
data, nor have they been incorporated into prospective trials. ‘Dynamic treatment regimes’ (DTRs) are rules for
making treatment decisions sequentially at multiple time-points based on a patient’s evolving history. Most
relevant treatment strategies for ARDS are DTRs. DTRs may be evaluated in randomized trials, however it is
infeasible to conduct randomized trials testing all DTRs of interest. This grant proposes ‘target trial emulation’
from observational data using ‘g-methods’ for confounding adjustment to address multiple gaps in our knowledge
about ARDS care. We will address important methodological gaps in ARDS phenotyping and develop advanced
machine learning (ML) methods for dynamic phenotyping for prognostication and personalized DTRs to
determine for whom and when specific ARDS treatments are beneficial. The investigation will utilize three large
datasets—including the Medical Information Mart for Intensive Care (MIMIC) IV database, the eICU collaborative
research database, and the Dutch AmsterdamUMCdb database—representing a wide geographic and
demographic spectrum, and the ability to assess stability of findings across geography and centers. To address
these knowledge gaps regarding use of NMB, steroids, driving pressure and mechanical power, as well as
identify phenotypes of patients most responsive to treatment, we propose two overarching aims for this grant.
Specific Aim 1) Using target trial emulations and g-methods, we will estimate clinical outcomes that would result
under a range of treatment strategies for NMB, steroids as well as driving pressure and mechanical power
thresholds. Specific Aim 2) We will develop machine learning methods to derive dynamic markers for ARDS
phenotyping and formulate personalized DTRs for ARDS treatment. The project represents a collaborative effort
between experts in critical care medicine (with a specialty in mechanical ventilation), machine learning, and
causal inference. Our results will address important gaps in clinical knowledge about treatment of ARDS and
inform the design of future randomized trials. Our study designs, code, and constructed cohorts will also
provide valuable templates for other researchers to use in future observational studies, which we foresee will
broadly improve the quality of evidence from observational data in critical care.

Public health relevance
PROJECT NARRATIVE This grant proposes using ‘target trial emulation’ from observational data using ‘g-methods’ to perform causal inference modeling, to test multiple ‘dynamic treatment regimes’ and developing advanced machine learning methods for dynamic phenotyping of acute respiratory distress syndrome (ARDS), addressing multiple important clinical and methodologic gaps in our current knowledge in ARDS treatment, utilizing three large existing public datasets including the Medical Information Mart for Intensive Care (MIMIC) IV database, the eICU collaborative research database, and the Dutch AmsterdamUMCdb database which represent a wide geographic and demographic spectrum of patients. We will utilize these advanced statistical and machine learning methods to answer specific gaps in the knowledge related to initiation, duration and termination of neuromuscular blockade and steroids, dynamic markers for initiation, and thresholds of treatment for driving pressure and mechanical power in addition to phenotyping for treatment effect heterogeneity and prognostication. Our results will address important gaps in both methodologies and clinical knowledge regarding treatment in ARDS and inform the design of future randomized trials, identifying effective treatment regimes, phenotypes of patients who could benefit from treatment and developing re-usable templates and resources from multiple large international ICU datasets for target trials and other observational studies of ARDS.